Transcription Factor Network-Mediated Modulation of Transitional Senescence States

Abstract. The maintenance of a differentiated cell type (i.e., cell identity), a feature established by cell type-
specific transcriptional programs, is critical for cell function and tissue homeostasis. Yet, despite acquiring a
specific function, the differentiated cell remains a plastic entity which retains the ability to functionally reprogram
itself in response to incoming signals while simultaneously maintaining its identity. To maintain this plasticity, the
cell relies on transcription factor (TF) networks that access, interpret and implement genomic information. Upon
receiving and processing an incoming signal (whether developmental, environment or damage), the cell
responds by rewiring its TF network. In some instances, the processing of the incoming signal rewires the TF
network and destabilizes cell identity leading to a transitional cell state with reduced function known as
senescence. Originally described as a stable proliferative arrest, senescence has recently emerged as a
transitional cell state heavily linked to the aging process and development of diseases such as osteoarthritis
(OA), cancer and fibrosis. The resolution of this transitional state can lead to outcomes linked with disease
development, including cell death, stabilization of senescence or disease states (Graphical Abstract). With this
understanding, we hypothesize that transitional senescence states represent critical intermediates that could
be manipulated for therapeutic applications. Given the overarching contribution of senescent cells to pathological
processes such as aging, cancer and fibrosis, manipulating senescence states has tremendous potential for
restoring cellular and tissue function across many diseases. The chief focus of our research program is to
define and manipulate the gene regulatory networks that dictate the transition through senescence states. To
achieve this goal, we employ an unbiased approach that involves the generation of TF network models from bulk
and single-cell time-series high-throughput sequencing epigenomic data from primary human cells representing
various tissues undergoing senescence-associated transitions linked to disease development. Using the TF
network model as a logical structure to validate and guide the manipulation of senescence states, we target
critical nodes using reverse genetics, genome editing and pharmacological approaches, and confirm key findings
in human samples using senescent cell isolation methods. Over the next 5 years, the main goals of our research
program are: 1) To generate TF network models of primary human chondrocytes (to model OA) and hepatic
stellate cells (HSCs, to model fibrosis) undergoing replicative and cytokine-induced senescence (RS and CIS),
2) To test the prognostic potential of senescence-linked epigenomic signatures using publicly available human
datasets, and 3) To develop strategies to restore the function of senescent cells by modulation of their TF
network. The overall vision of the research program is to design and implement strategies to reprogram
senescent cells across multiple diseases. If successful, this research program will pave the way toward a new
era of cell therapy in which diseased cells could recover their function through TF network reprogramming.

Public health relevance
Project narrative Transcription factor (TF) networks access, decode and implement genomic information to provide a differentiated cell with its identity as well as the plasticity to respond to incoming signals (such as environmental and developmental cues). In some instances, incoming signals can destabilize TF network function and force the cell into a dysfunctional state known as senescence, which promotes disease across multiple tissues. In this proposal, we will harness the power of time-resolved multiomic profiling to define and manipulate the TF networks of cells transitioning through senescence states linked to disease as a novel approach to restore cell function and to develop diagnostic/prognostic tools for disease monitoring, potentially paving the way for a new era of epigenomic medicine.